Regulation of Gammaherpesviral Late Gene Expression

ABSTRACT
Herpesviruses are endemic within the human population, and cause a wide range of life-threatening diseases.
Members of the betaherpesvirus and gammaherpesvirus subfamilies are extremely problematic in
immunocompromised individuals, leading to severe congenital disorders and a variety of cancers. This
proposal will define how a critical class of herpesviral genes are expressed late in the lifecycle of Kaposi's
sarcoma-associated herpesvirus (KSHV) through a mechanism that involves a novel transcription complex,
which combines both viral mimicry and co-option of select host machinery. The set of viral proteins required for
late gene activation are broadly conserved among the beta- and gammaherpesviruses, indicating that
information gained herein for KSHV will likely be applicable for Epstein-Barr virus and human cytomegalovirus
as well. The focus of this grant is to define the composition and regulation of this novel gene expression
complex, and reveal how its function is linked to viral genome replication. Given that even subtle mutations in
this late gene transcription complex effectively `kill' the virus, an understanding of its composition and
regulation is anticipated to reveal new targets for antiviral strategies.

Public health relevance
PROJECT NARRATIVE Kaposi's sarcoma-associated herpesvirus (KSHV) is an emerging Group 1 pathogen and the major cause of cancers in untreated AIDS patients. KSHV, like other DNA viruses, expresses a class of genes late during infection that are essential for viral assembly and escape from their host cell, but how the expression of these genes is regulated has long remained unknown. This grant is focused on revealing how a group of KSHV proteins orchestrates this process though a combination of molecular mimicry and co-option of host gene expression machinery.